Illumina NovaSeq X Plus High Throughput DNA Sequencer for Emory University

PROJECT SUMMARY/ABSTRACT:
The Emory National Primate Research Center Genomics Core (GenCore) is requesting support to acquire an
Illumina NovaSeq X Plus Sequencing System. Since 2011, the EPC Genomics Core has served a diverse
collection of EPC and Emory University investigators; assisted in planning, preparing, and executing projects
having dynamic deep-sequencing needs. From the characterization of genome-wide DNA methylation profiles
in the context of neurodegeneration, to identifying differentially expressed genes following various vaccination
regimens, the GenCore has worked closely with investigators to successfully meet the demands of their research
programs. Over the past several years, massively parallel deep sequencing has made significant contributions
to biomedical research– particularly due to increased affordability and practicality over more conventional
approaches to gene sequence and expression characterization. Our growing user base, and the increased
sophistication of our users' needs, requires the GenCore to replace our existing Illumina NovaSeq 6000 with the
NovaSeq X Plus, which will decrease turn-around time, decrease sequencing costs, and increase the volume of
samples that can be sequenced simultaneously. The NovaSeq X Plus will bring genome-center capabilities to
the EPC GenCore– investigators will have in-house access to genome-scale deep sequencing services with
corresponding informatics support. Our users, minor and major, correspond to investigators leading their field,
and supporting their evolving sequencing needs by acquiring an Illumina NovaSeq X Plus will undoubtedly
benefit the larger scientific community.

Public health relevance
PROJECT NARRATIVE: Genome sequencing technology has increased the rate at which biomedical research projects are able to ask and answer complex questions. The goal of this proposal is to obtain an Illumina NovaSeq X Plus next-generation sequencing platform for our sequencing facility. The NovaSeq X Plus will provide a transformative upgrade to our current sequencing technology that will significantly enhance the biomedical research programs at Emory University and within the greater Atlanta area.